Leveraging consanguinity and homozygosity to identify novel recessive variants

PROJECT SUMMARY/ABSTRACT
Genome-wide association studies (GWAS) traditionally assume an additive model of
genetic inheritance, where the genetic effect of a heterozygous genotype is exactly
intermediate to the genetic effects of the two homozygous genotypes. However, we know
that many alleles act in either a dominant or recessive fashion. Detecting the phenotypic
effects of rare, recessive variants is especially challenging, due to the scarcity of rare,
homozygous genotypes. Here, we propose to use data from 96,000 individuals from the
Pakistan Genomic Resource (PGR) to quantify the effects of rare, recessive variants on a
wide range of phenotypic traits and common, complex diseases. Our study leverages the
high rates of inbreeding within the PGR (which increases the frequency of rare,
homozygous genotypes), as well as extensive lifestyle, family history and genetic data from
all participants. The specific aims for our project are (1) Phase and impute variants into
more than 96,000 PGR genomes using a reference panel that includes 6,200 high-
coverage genome sequences from South Asia; (2) Test for associations between a wide
range of phenotypes and genotype, using a combination of standard single-variant tests
and novel homozygosity-mapping approaches; and (3) Infer historical models of
consanguinity within the PGR, using the distributions of long runs of homozygosity (caused
by consanguineous marriages) both within and between individuals.

Public health relevance
NARRATIVE The Pakistan Genomic Resource (PGR) is a unique cohort of individuals with extensive phenotypic data and high rates of consanguinity. We plan to leverage these attributes, along with the availability of genome-wide genotype data from PGR samples, to discover novel genetic variants that can help predict disease susceptibility and help improve our understanding of the genetic contributions to medically relevant biomarkers such as blood pressure and cholesterol levels.